Nonalcoholic Fatty Liver Disease (NAFLD) in Polycystic Ovary Syndrome: The Role of Androgens on Liver Injury and NAFLD Progression

ABSTRACT
Rates of cirrhosis from nonalcoholic steatohepatitis (NASH) are rapidly rising in young adults, and given limited
therapies and the heterogeneity of affected individuals, there is an urgent and unmet need to identify tailored
therapeutic targets for at-risk young populations. Androgens may reflect such target for the 10-15%, or nearly
10 million reproductive-aged women with Polycystic Ovary Syndrome (PCOS). PCOS is typically marked by
elevated androgens, and over 50% of these women have NAFLD. We have shown PCOS to increase the risk
of prevalent NASH and advanced NASH fibrosis, which occurs at a younger age than in non-PCOS controls.
High androgens may explain their observed “head start” in disease severity, as our cross-sectional data from
young women without PCOS found higher (though normal range) testosterone levels to be associated with
NASH fibrosis. Whether elevated androgens underlie the risk of liver injury in PCOS, and the potential
mechanistic pathways by which this occurs, are not known. Our findings would support androgen receptor
antagonism as a potential therapeutic target for the large population of women with PCOS and liver disease.
Our central hypothesis is that androgens promote liver injury and NASH progression in PCOS, which occurs
through aberrant lipid activity (including lipotoxicity and dysregulated de novo lipogenesis), in part from
androgenic effects on visceral fat. Exogenous androgen use in women does increase visceral fat, which in turn
promotes NASH through several pathways, including production of lipotoxic lipid species. Androgens are also
linked to dysregulated branched-chain amino acid metabolism in PCOS, which is relevant as co-investigators
on our team have discovered an enzymatic imbalance that leads to dysregulated hepatic de novo lipogenesis
and NASH, and is reflected by serum levels of branched-chain amino and ketoacids.
Building upon these data, we propose a 2-center (UCSF and Duke) longitudinal study of 150 reproductive-
aged women with NASH (125 PCOS and 25 non-PCOS controls) to determine the influence of androgens on
liver injury and progression in PCOS and the mechanistic contributions of visceral adiposity (Aim 1) and
aberrant lipid metabolism (Aim 2) to this process. Aim 3 is a mechanistic proof-of-concept trial of 50 PCOS
participants to determine whether 24 weeks of androgen receptor blockade improves lipid metabolites that
reflect hepatic lipotoxicity and dysregulated de novo lipogenesis, respectively, as well as imaging-quantified
hepatic and visceral fat, and NASH histology. Leveraging our existing UCSF PCOS cohort and the established
infrastructures and collaborations between UCSF and Duke in NAFLD, PCOS, obesity, and lipid metabolism,
we are well positioned to accomplish the proposed aims. Impact of findings: Determining the contribution of
androgens to liver injury in PCOS and the underlying mechanistic pathways will support efficacy studies
evaluating androgen receptor antagonism for NASH, or the need to target lipid-specific pathways as a tailored
approach to halt NASH progression in this hormonally-distinct and metabolically high-risk population.

Public health relevance
PROJECT NARRATIVE The public health implications of nonalcoholic steatohepatitis (NASH) in young adults is vast, and given limited therapies and the heterogeneity of affected individuals, there is an urgent and unmet need to identify tailored therapeutic targets for distinct at-risk populations. Androgens may reflect such target for the 10-15%, or nearly 10 million reproductive-aged women with Polycystic Ovary Syndrome (PCOS), a common endocrinopathy with classically elevated androgens, that is marked by early onset NAFLD and greater risk of NASH. In the proposed study, we will determine whether androgens are the driver of NASH severity and progression in PCOS and the mechanistic contributions of visceral fat and aberrant lipid metabolism to this process – findings that are directly relevant to future efficacy studies evaluating androgen modulation in these young women with early onset liver disease.